Non-Invasive Measurement of Pulmonary Dysfunction in Children with Cerebral Palsy

Project Summary
This R21 application proposes the utilization of a novel non-invasive real-time breathing sensor –
pneuRIP- to measure pulmonary function (PF) in children with high-level cerebral palsy. Currently the standard
measures of PF such as spirometry and peak flow meters are too strenuous for children and those with severe
CP, as a result they have low compliance rates. The pneuRIP does not require active user participation and
can passively measure PF. It consists of two inductive bands worn around the chest and abdomen that
measure and differentiate diaphragmatic and chest breathing through Respiratory Inductance
Plethysmography (RIP). Readings are recorded and analyzed on a small chest-worn unit and wirelessly
transmitted to an iPad. The pneuRIP yields indices of work of breathing (WOB) which includes the phase angle
between the chest and abdomen; percentage breathing through the ribcage; respiratory rate; and labored
breathing index. This sensor takes little time to set up and readings are provided instantaneously.
The WOB indices provide a screening tool for pulmonary diagnosis and treatment, decrease the risk for
pneumonia and respiratory illness, and has the potential to act as a marker for scoliosis in children with high-
level CP. Our research team (clinicians, basic scientists, bioengineers & therapists) has shown the
effectiveness of the proposed PF methodology in both intensive care, emergency departments, operating
rooms, and neuromuscular clinics.
The impact on the field will be to have a simple and fast way to measure pulmonary function in children
and adults with severe CP and correlate this to measures of function and scoliosis severity as the effects of
scoliosis, which is common in CP, on pulmonary function is unclear. Measures of motor function are classified
by the Gross Motor Functional Classification System (GMFCS), ranking from I to V, with worsening disability
from near normal gait in Type I to complete wheelchair use in Type V. This project will address GMFCS levels
IV and V which includes people using wheelchairs. The two specific aims are a) Measure WOB indices non-
invasively using the pneuRIP sensor in children with CP who use a wheelchair (GMFCS level IV, V) and
validate the use of WOB indices as a screening test for pulmonary dysfunction., 2) Determine the correlation
between WOB indices and the degree of scoliosis using the pneuRIP sensor in 250 children with CP who use
a wheelchair (GMFCS level IV, V). The proposed research is innovative because this RIP technology to date
has not been incorporated in the diagnosis and treatment of children with CP. The advantages include
provision of the diagnostic data in real-time, less stress to the patients, and a reduction in lab testing and
imaging. Collectively, we expect the outcomes of these clinical studies will greatly add to pulmonary treatment
in CP.

Public health relevance
This proposal addresses pulmonary dysfunction in severe cerebral palsy by using a novel non-invasive respiratory sensor. The two aims of the project are to 1) provide a screening tool to detect respiratory distress and 2) Find a correlation between the degree of pulmonary dysfunction and scoliosis in children with cerebral palsy.